Resting State Connectivity in Primate Spinal Cord

ABSTRACT / SUMMARY
This proposal aims to continue our research to identify and characterize resting state functional MRI
signals within the grey matter of the spinal cord, and to validate the interpretation of resting state functional
connectivity (rsFC) networks in the spine that appear to reflect specific, behaviorally-relevant functions. In the
current funding period we have found resting state networks within the cord exhibit more complex connectivity
than previously reported, both within and across segments, including significant correlations with the
intermediate region and grey commissure that are relevant for autonomic functions and left-right coordination.
Importantly, by implementing a dorsal column injury to the cervical spine in a non-human primate, we have
confirmed that the strengths of connectivity within these networks are in general related to functional
performance, and changes in the networks correspond to behavioral changes in, for example, skilled hand use.
We next aim to fully characterize the sub-components of rsFC and relate them to more specific functions. We
will acquire sub-millimeter, multi-parametric MR images at high field (9.4T) in squirrel monkeys and address
three main aims. (1) We will identify and differentiate rsFC networks within spinal cord using selective lesions
and pharmacological interventions to determine which components and network connectivities are affected by
specific disruptions of normal sensory or motor pathways. We will isolate circuits affected by (a) reversible
block of motor or sensory inputs with pharmacological agents; (b) permanently ablating the drive of motor
neurons from primary motor cortex in ventral horn; and (c) disrupting sensory signals to dorsal horn neurons by
sectioning dorsal spinal nerve roots. We will follow the evolution of each injury using CEST and DTI to
measure the extent and severity of the injury, and DTI and qMT to validate injury severity and quantify changes
in axonal integrity and myelination. (2) We will validate the rsFC measures from MRI by comparisons with
electrophysiology, micro-stimulation and tract-tracing histology. We will (a) directly stimulate specific nodes
while monitoring down-stream activity with electrophysiology and fMRI; (b) perform longitudinal fMRI and
microarray recordings of electrical coherences in each monkey subjected to specific interventions (Aim 1); and
(c) determine whether regions which appear to be functionally connected by fMRI also show strong anatomical
connections by injecting tracers and performing histological assessments post mortem. (3) We will determine
the functional and behavioral relevance of rsFC by disrupting each circuit, identifying corresponding changes
in rsFC, and relating these changes to performance of skilled hand sensorimotor behavior. By the completion
of the study, we will validate rsFC measurements as indicators of spinal cord functions, and establish the fine-
grained intrinsic architecture of intra-spinal circuits. These studies will provide new information on the neural
organization of the spinal cord, validate the interpretation of BOLD measurements of connectivity, and provide
a roadmap for the use of fMRI for studying human spinal cord functions.

Public health relevance
Narrative The studies proposed will identify and differentiate neural networks within the grey matter of the spinal cord that subserve different functions and which may be detected using functional MRI. The patterns of connections between different sub-regions of the cord will be quantified before and after targeted interventions that are intended to disrupt specific functions. The interpretation of functional MRI measurements will be validated using electrophysiology and post-mortem histology.